PharmaLink Conference

Project Summary
The key objectives of the PharmaLink Conference are:
 Open collaboration and engagement with FDA and industry to discuss pharmaceutical challenges and
opportunities.
 Identify innovative solutions for rising issues in the pharmaceutical industry and across healthcare.
AFDO proposes the PhamaLink Conference plan to follow this format:
 During years 2023-2024 there will be an in-person conference with presentations and facilitated
discussions on identifying and building innovative and collaborative solutions to be used in the
pharmaceutical industry to advance patient care.
During each conference, a group of 130+ Pharmaceutical leaders from all areas of the industry will come
together to lead innovation around the issues surfaced during the collaborative opportunities between
industry and regulators.

Public health relevance
Project Narrative The relevance of the PharmaLInk Conference to public health is to bring the industry and regulatory communities together to advance the health industry’s understanding on rising issues, challenges, and opportunities that can arise from collaboratively innovating together to address challenges across the pharmaceutical industry.